Mouse Immunization/Challenge

ABSTRACT
The overall objective of the Core E: Mouse Immunization/Challenge Core is to provide centralized testing of
candidate gonorrhea vaccines developed by Projects 1, 2, 3, and 4 in immunization/challenge studies to
identify the most promising gonococcal vaccine antigen(s) and candidate vaccines. The standardization of the
mouse immunization/challenge experiments by Core E for vaccines developed by all projects is critical for the
overall success of the Gonorrhea Vaccine Cooperative Research Center (GV CRC). To accomplish the goals
of Core E, centralized vaccine testing will be performed in the following three female mouse infection models
with accompanying statistical analyses to identify correlates of protection: 1) Lower Reproductive Tract
Model: Core E will conduct initial testing of all vaccines in a well-established mouse model of Neisseria
gonorrhoeae (Ng) lower reproductive tract (LRT) infection; 2) Upper Reproductive Tract Model: Vaccines
that show efficacy in the LRT model will be tested in a novel model of Ng upper reproductive tract (URT)
infection to verify efficacy in both anatomical sites; 3) Gonorrhea/Chlamydia Coinfection Model: Final testing
will include evaluation in a Ng/Chlamydia muridarum coinfection model to determine whether efficacy is
maintained in the context of simultaneous infection with another immunosuppressive organism; 4) Statistical
Analyses for Correlates of Protection: Cox proportional hazard regression analyses will be performed on
combined data generated by the Cores C, D and E to identify correlates of protection. This centralized testing
and analyses of the vaccines will ensure that the best gonorrhea vaccine is identified for advancement into
clinical trials.